ADMINISTRATIVE CORE

The Administrative Core will be directed by Brown and co-directed by Szapocznik, Pantin, Prado, and Wingood, who have all been introduced in Secfion 4.A.2.a. This core will be responsible for the day to day operations of the entire Center. This Core will coordinate Center activities and collaborations across investigators, be responsible for organization and implementation of Center meetings and training activities, and oversee all fiscal management and human resources-related activities. Core members will meet weekly in their respective subcommittees to outline the week's tasks and monitor progress of ongoing initiatives including publications, grants, mentoring, and conferences. It will have three subcommittees: A) Mentoring B) Pilot Research Projects, and C) Communications. Each will be co-lead by a Center scientist and involve one or more New Investigators. The directorships will remain constant throughout the 5 year funding period to give the Subcommittees stability and clear focus over time.